Do auditory tests predict future Alzheimer’s disease pathophysiology

Hearing loss has been considered a risk factor for Alzheimer’s disease (AD), but the underlying mechanism
remains elusive. A “bottom-up” hypothesis has been suggested, where peripheral or cochlear damage at the
“bottom” of the auditory pathway accelerates AD pathophysiology by sensory deprivation. This hypothesis is
attractive because it suggests interventions to improve hearing might slow or prevent progression towards
dementia. Alternatively, a “top-down” relationship may exist where protein deposition within the brain at the
“top” of the central auditory processing pathway impairs the brain’s ability to process sound. Our group studies
how conditions that produce diffuse brain damage, such as HIV infection, affect the brain’s ability to process
complex sounds (central auditory processing). The results show a relationship between performance on central
auditory processing tests and cognitive function in individuals living with HIV. This finding led to a NIH-funded
supplement to our HIV work to examine these associations in AD. AD is the leading cause of dementia and is
defined by the presence of cerebral amyloid-β plaques and tau neurofibrillary tangles. Our results from the
supplement show that amyloid-β plaques and tau tangles detected by PET correlate better with central, rather
than peripheral, auditory test results in a sample containing both mild cognitive impaired due to AD and
cognitively unimpaired individuals. The present project will expand this work and assess the relationship of
both peripheral and central auditory test performance to longitudinal amyloid-β and tau tangle deposition in
the brain. The relationship to cognitive performance will also be examined. If the “bottom-up” hypothesis is
correct, individuals with poor peripheral hearing at baseline, but age and hearing level appropriate central
auditory test results, should show a faster rate of protein accumulation over time compared to those who do
not. If the “top-down” hypothesis is correct, poor baseline central auditory test performance, relative to age and
peripheral hearing function, should show a strong relationship to the rate of brain protein deposition. These
findings could provide a mechanistic understanding of the relationship of performance on auditory tests to AD
pathophysiology. Also, auditory tests are objective, straightforward, and relatively insensitive to educational
and socioeconomic status. If they predict, or correspond with, anatomic disruption in AD, they may be useful
for assessing disease progression or the response to treatment over time.
The proposal will leverage, and enroll participants into, the TRIAD cohort, a longitudinal biomarkers-based
cohort at the McGill University Research Center for Studies in Aging. Participants in this cohort, have PET
imaging to detect amyloid-β and tau protein aggregation. In addition to imaging, neurocognitive testing is
performed and biosamples (including cerebrospinal fluid) are collected. These data, combined with the auditory
tests, will provide the unique ability to determine the relationship between auditory function and multiple
biomarkers associated with AD.

Public health relevance
Project Narrative Poor hearing relates to Alzheimer’s disease, but whether poor hearing ability accelerates the progression of Alzheimer’s disease or is mainly a symptom of the underlying brain injury from Alzheimer’s disease is not understood. This project will use an objective marker of Alzheimer’s disease—protein deposition in the brain— to determine the relationship between hearing ability and the progression of Alzheimer’s disease. This will provide definitive information on how hearing loss contributes to or reflects Alzheimer’s disease progression.